Immunology Team Contributions to the LSB

We previously developed a model system for employing the tools of systems biology to investigate the unexplored roles of many NLRs. In the course of such study, Dr. Subramanian (now leading her own laboratory at the Institute for Systems Biology) observed profound effects of very small changes in intracellular protein concentration on signaling through the NOD1 pathway. Under normal conditions, several miRNAs contribute to maintaining expression of NOD1 below the level leading to ligand-independent gene activation. Alteration in expression of these miRNAs is linked to an increases severity of gastric cancer, which was previously linked to NOD1. These data may be of importance in understanding how small eQTLs linked to inflammatory and autoimmune diseases operate to cause pathology. Based on these findings, we are exploring in various experimental systems whether small (1-2 fold changes in gene expression, as seen with many eQTLs), can lead to disease by imbalancing activation and negative regulatory pathways. We suspect this type of dysregulation might contribute to various autoimmune states. Preliminary data indicate that clonal T cell populations vary in both protein expression and in associated functional capacity and that these states vary over time in the absence of cell division. This suggestion of time fluctuations in cell state have important implications for better understanding when individual immune cells respond to perturbations, when they might exceed regulatory control thresholds, and how small eQTL-level differences in average gene expression might contribute to disease propensity.

Based on successful testing of a highly quantitative method for protein quantification by mass spectroscopy, we are engaged with other members of the LISB in developing robust datasets quantifying in a time resolved manner the post-translational modifications of proteins induced upon TLR ligation and building computational models of the TLR signaling process based on these data using the Simmune platform.